ASSESSING THE SAFETY OF RECOMBINANT HUMAN CILIARY NEUROTROPHIC FACTOR (RHCNTF)

This study aims to assess the safety and tolerability of single doses of recombinant human ciliary neurotrophic factor in patients with a) newly diagnosed, non-small cell carcinoma of the lung, b) recurrent head and neck tumors, or c) low grade, non-Hodgkin's lymphoma.